Colonic bile acid metabolism and responses in African Americans and non-Hispanic Whites

PROJECT SUMMARY/ABSTRACT
African Americans (AA) have among the highest colorectal cancer (CRC) incidence and mortality in the US.
Environmental factors influenced by social determinants of health, especially high fat diets, are known to
increase CRC risk, but how these factors contribute to CRC disparities is largely unknown. Bile acids (BA),
produced in response to dietary fat, are converted by the gut microbiome to secondary BA, especially
deoxycholic acid (DCA) and lithocholic acid (LCA), that can be carcinogenic in the human colon. Previous
studies suggested differences in BA concentration and metabolism between AA and non-Hispanic Whites
(NHW), but these preliminary findings require rigorous validation and further investigation. Colonic responses
to BA could also differ between populations and modulate CRC risk. We developed an innovative experimental
framework using colonic organoids to study host-environment interactions in colonic tumorigenesis that has
been successfully applied to identify cancer-related, inter-ethnic responses to relevant environmental factors.
In this proposal, we will study 3 aspects of BA metabolism to determine if there is a connection to CRC risk and
observed CRC disparities. As an R21 proposal, the goal is to test the hypothesis of population differences in
one or more of these factors that, if found, would then be studied through mechanistically-focused
investigations in the future. Specifically, we will: 1) Compare serum BA composition in self-identified AAs and
NHWs leveraging a prospective study called COMPASS, 2) perform microbiome profiling in tissue and stool
from AAs and NHWs with specific attention to pathways involved in BA conversion, and 3) test for differences
in transcriptional and cellular responses to DCA and/or LCA in colonic organoids from individuals of African
and European descent. Importantly, we will control for relevant covariates such as age, sex, diet and social
determinants of health (e.g., area deprivation).
If one or more of these hypotheses is confirmed, our results will provide critical preliminary data to support a
future proposal to dissect underlying mechanisms of observed differences in BA metabolism and colonic
responses between populations and how these could impact CRC disparities. This study has potential for high
impact to elucidate the interrelated roles of diet, BA metabolism and colonic responses in CRC disparities that
could translate into future “precision prevention” trials and new biomarkers of CRC risk especially in AAs who
experience unequal burden of disease.

Public health relevance
PROJECT NARRATIVE Bile acids, produced in response to high fat diet, are converted to secondary bile acids by the gut microbiome and can cause cancer in the human colon. Little is known about the role of colonic bile acid metabolism in colorectal cancer disparities especially among African Americans who experience unequal burden of disease. The goal of this study is to determine if there is a connection between bile acid metabolism, responses and colorectal cancer risk in African Americans and non-Hispanic Whites.